Molecular basis for CRISPR RNA-guided nucleic acid cleavage and DNA transposition

PROJECT SUMMARY
CRISPR-Cas systems provide adaptive immunity in bacteria and archaea by employing guide RNAs and
endonuclease effectors to specifically recognize and cleave invasive nucleic acids. The specific DNA targeting
and cleavage activities of CRISPR-Cas systems have been adopted and developed for genome editing and
various other applications, which are revolutionizing biomedical research and beyond. However, safety
concerns are raised because of off-target genome editing and the dependence of these systems on
endogenous host DNA repair pathways, hindering clinical application. Exploration of alternative CRISPR-Cas
systems in nature not only offers an opportunity to overcome those challenges but may also inspire new
applications. Structural and biochemical characterizations of CRISPR-Cas systems are critical for
understanding their mechanisms and repurposing them for precise genome editing. Our long-term goals are to
unravel the mechanisms underlying target nucleic acid recognition and cleavage mediated by type V and
transposon-associated CRISPR-Cas systems, which provide essential knowledge for safer and more reliable
application in treating human disease. In this proposal, we will work on the molecular mechanisms for four
newly discovered CRISRP-Cas systems, covering DNA targeting (Cas12i), RNA targeting (Cas12g), and
CRISPR RNA-guided DNA transposition (type I-F Cascade and Cas12k). As revealed in our preliminary data,
Cas12i accommodates a longer crRNA-DNA heteroduplex than currently used Cas effectors, thus potentially
improving specificity for genome editing. The RNA-guided RNase Cas12g is compact and thermostable,
highlighting its potential for RNA editing and RNA targeting. Furthermore, type I-F Cascade and Cas12k direct
transposition machinery for RNA-guided DNA transposition, opening a new paradigm for genome editing
independent of DNA repair pathways.
1

Public health relevance
PROJECT NARRATIVE CRISPR-Cas systems have been developed into genome editing technologies that are revolutionizing biomedical research and clinical applications. Our proposed studies aim to understand the structure and molecular basis of newly discovered type V and transposon-associated CRISPR-Cas systems that could be used to overcome challenges and limitations of current tools. 1